Understanding how alveolar epithelial cell stress drives aberrant repair in interstitial lung disease

PROJECT SUMMARY
Interstitial lung diseases (ILDs) are a class of pulmonary diseases pathologically defined by interstitial fibrosis
and inflammation. Owing to our limited understanding of the upstream initiators of pathogenesis, ILDs have poor
prognoses and limited therapeutics. Mutations in the Alveolar Epithelial Type 2 Cell (AEC2) restricted Surfactant
Protein C (SP-C) gene (SFTPC) in a subset of ILD patients supports a growing hypothesis that AEC2
dysfunction is a driver of disease. When we model these disease-related SFTPC mutations in vitro they
segregate into two major classes based upon how the mutated SP-C isoform stresses cellular pathways that
manage abnormal proteins: mutations that inhibit macroautophagy and mutations that cause endoplasmic
reticulum (ER) stress. However, how these AEC2 stress phenotypes, which have also been identified in ILD
patients without SFTPC mutations, relate to ILD development remains poorly understood.
To understand this relationship, we have generated two unique Sftpc mutation knock-in mouse models, one
expressing an SP-C isoform that induces AEC2 macroautophagy dysfunction (SP-CI73T) and the other inducing
ER stress (SP-CC121G). Each of these mutations when expressed in the adult mouse lung results in spontaneous
alveolitis and lung injury followed by aberrant repair with resultant fibrotic ILD. These models thus provide proof
of concept that AEC2 stress is capable of driving spontaneous lung pathology and are robust preclinical
platforms. These models also support a second emerging theory of ILD pathogenesis: that in ILD AEC2s, which
must act as critical facultative progenitor cells after lung injury by both proliferating and differentiating to repair
damaged epithelium, develop dysfunction in their progenitor cell capacity. We discovered that while similar lung
pathology develops in each of our Sftpc models, there are divergent AEC2 proliferation phenotypes following
lung injury: SP-CI73T AEC2s become hyperpoliferative and SP-CC121G AEC2s become apoptotic and
hypoproliferative. Thus, our models support the hypothesis that abnormal AEC2 progenitor cell function plays a
central role in ILD development, and also create a platform to develop a mechanistic understanding of how
discrete AEC2 stress signatures result in distinct defects in progenitor cell capacity.
This proposal has three interrelated aims that seek to understand the molecular and cellular mechanisms that
relate AEC2 cell stress, dysfunctional progenitor cell capacity, and ILD. Aim 1 uses bioinformatics and in vivo
linage-tracing to characterize the AEC2 stress signaling and progenitor function pathways involved in each
model. Aim 2 provides a mechanistic link between cell stress signaling and progenitor cell dysfunction through
ex vivo organoid culture and in vivo modeling. In Aim 3 we will generate the first ILD patient-derived iPSC
culture model of an ER stress associated SFTPC mutation as a humanized platform to study the pathways
identified in Aims 1 and 2. This proposal will also provided the trainee with the diverse and comprehensive
training necessary to develop a multimodal independent research program on the role of the epithelium in ILD.

Public health relevance
PROJECT NARRATIVE Interstitial lung diseases (ILDs) are a devastating form of chronic disease in adults and children marked by progressive respiratory failure for which there are limited therapeutics due to poorly understood disease development and progression. Activation of cell stress pathways in alveolar epithelial type 2 cells (AEC2s), an epithelial cell that line the air sacs (alveoli) of the lung, and dysfunction in their ability to repair injured lung have emerged as leading paradigms for why ILD develops and progresses. Coupling two novel mouse models that express Surfactant Protein C (SP-C) gene mutations that are associated with human ILD with state-of-the-art modeling using cells derived from an ILD patient with an SP-C mutation, we now aim to better understand ILD development and to identifying therapeutically targetable pathways by characterizing the molecular and cellular mechanisms that link AEC2 cell stress and dysfunctional lung repair.